Regulation of PTH secretion by TRPC1

Primary hyperparathyroidism is the one of the most common endocrine disorders. Primary
hyperparathyroidism results from parathyroid adenomas while secondary hyperparathyroidism results from
parathyroid gland hyperplasia in the setting of renal disease. Both conditions are associated with decreased
expression of the Ca2+ sensing receptor (CaSR) which is required to suppress parathyroid hormone (PTH)
secretion in the setting of hypercalcemia. Understanding the molecular mechanisms that regulate PTH
secretion downstream of CaSR is critical for the discovery of new therapeutics to treat hyperparathyroidism
and its associated morbidity. Here we show for the first time that Tprc1-null mice develop primary
hyperparathyroidism, hypercalcemia, and low urinary calcium excretion mimicking the human disease Familial
Hypocalciuric Hypercalcemia (FHH). FHH is a form of primary hypeparathyroidism and caused by inactivating
mutations in CASR, GNA11 and AP2S1 encoding CaSR, the α11 subunit of the guanine nucleotide-binding
protein, and the σ1 subunit of the AP2 clathrin-associated adaptor complex mediating recycling of cell surface
receptors and channels, respectively. Thus, we tested whether TRCP1 function is directly linked to CaSR
signaling. Biochemical, functional, and cell biological experiments in vitro show that TRPC1 is activated by
CaSR involving the action of Gα11. We also show that TRPC1 physically interacts with AP2σ1. These data
lead us to the hypothesis that TRPC1 is required for normal suppression of PTH secretion in the parathyroid
gland by acting downstream of CaSR via Gα11. The interaction of TRPC1 with AP2σ1 increases the
availability of TRPC1 for CaSR-induced signaling by accelerating recycling of inactivated TRPC1. In Aim 1, we
will employ cell biological approaches to define the mechanism by which TRPC1 mediates CaSR-induced Ca2+
signaling and the role of Gα11 and AP2σ1 in this signaling pathway in cells derived from the parathyroid gland.
In specific Aim 2, we will determine whether TRPC1 functions downstream of CaSR and Gα11 in vivo, by
asking whether compound mice lacking Trpc1 and Casr or Gnα11/Gnαq genes in their parathyroid glands
show more severe FHH-like phenotypes than phenotypes elicited by single gene deletions. Understanding the
pathways that regulate PTH secretion could have a high impact on designing new and more effective and
specific approaches to treat patients with primary as well as secondary hyperparathyroidism.

Public health relevance
Hyperparathyroidism affects ~1% of the population and is associated with significant cardiovascular morbidity and osteoporosis. In contrast, intermittent PTH administration (teriparatide) produces increased bone mass but the mechanisms by which intermittent PTH drives increased bone are poorly understood. The studies proposed here will address this unmet need as well as provide new insights into Ca2+ homeostasis and regulation of PTH secretion.